SkyScan 1276 uCT for multi-user biomedical studies

Project Summary/Abstract.
The overall goal of this project is to replace the current micro computed tomography (micro-CT) at Nova
Southeastern University (NSU) which is near to end of its life with a more advanced robust micro-CT, to
provide accurate and efficient analysis of mineralized tissue as well as vascular structure to the investigators,
accelerating and enhancing the research efforts at NSU and nearby institutions. Micro-CT has become an
indispensably robust equipment for 3-dimensional imaging of bones, teeth and vasculature. The currently used
micro-CT, production of which was discontinued by the manufacturer, may permanently stop working at any
time, placing the ongoing projects in a dire situation, most of which are funded by the NIH. Most of major and
minor users of micro-CT who have laboratories in the Center for Collaborative Research (CCR) belong to one
of four distinctive colleges of osteopathic medicine, pharmacy, dental medicine, allopathic medicine, in the
Health Professional Division, or in Guy Harvey Oceanography Center at NSU. In this resubmission, we are
joined with additional two major users from the neighboring Florida Atlantic University and University of Miami
(Total of 7 major users and 7 minor users). Those researchers propose their need for the new micro-CT
system in the field of bone regeneration, cancer biology, oral/craniofacial skeletal biology, HIV, antibiotic
resistance, aging associated bone lytic diseases, and oceanographic research. The new micro-CT system will
facilitate investigators at NSU to thrive in their research programs, as well as catalyze more internal and
external collaborations, while serving as an attractive feature for recruiting more research faculty. It will be
maintained as a core facility in CCR, and users will receive assistance from the designated operator and CCR
staff for instrument usage and data analysis. The well-versed experts in using micro-CT at NSU will ensure that
the new system will be fully utilized and well maintained. The Vice President of Research at NSU and Dean of
College of Dental Medicine (where four of the seven major users are affiliated with) fully support the proposal
and has agreed to provide full institutional support for the maintenance service, in addition to the retention of
currently designated operator's time, for at least 5 years. The oversight committee composed of in- and out-of-
house members will ensure the sufficiently efficient operation and use of the new micro-CT. The price of the
instrument $412,365.11, includes the micro-CT instrument with 3D analysis software, computers for
reconstruction and data analysis, and initial installation and training. In summary, based on 1) the well-justified
need of micro-CT for research at NSU, 2) extensive expertise with micro-CT technology, 3) the established
solid administrative structure and oversight committee for the core management, and 4) full institutional
commitment to maintain the micro-CT, this award will be a worthwhile investment that serves the missions of
the NIH and NSU.

Public health relevance
Our existing micro-CT in the core facility of Center for Collaborative Research (CCR) became dysfunctional which placed the NIH-funded researchers and other users of micro-CT in a dire situation. To this end, the S10 large grant mechanism is the only way for NSU researchers to obtain a new micro-CT (Bruker SkyScan 1276). Based on the following facts and condition available for this S10 application; 1) excellent panel of 7 major and 7 minor users who have research project that require micro-CT, 2) absence of high resolution in vivo micro-CT in any academic institution in South Florida, 3) experienced support staffs designated for the operation of the new micro-CT, 4) the efficient management and maintenance of all shared equipment in the CCR by Dr. Robin Krueger, NSU Director of Scientific Facilities, 5) the technical expertise of micro-CT operation available from Dr. Heidari, designated operator, and other major users who have experience in operating current SkyScan 1176 micro-CT, 6) well balanced oversight committee composed of internal and external researchers who are users and non-users, as well as 7) outstanding institutional support for the infrastructure and maintenance service, we are confident that the proposed acquisition of SkyScan 1276 micro-CT will strongly benefit the research and training at NSU and neighboring institutions in line with the mission of NIH.